Project Prakash: Development of Object Perception After Late Sight Onset

Project Summary
The World Health Organization estimates that globally nearly 13 million children are visually impaired, with over a
million of them being blind. Over 80% of these children reside in third-world countries, with bleak prospects for medical
care, even though in many cases, the conditions are treatable or preventable. The lives such children lead are difficult and
deprived ones. Project Prakash (Sanskrit for `light') was born out of the realization that the humanitarian mission of
bringing sight to blind children offers a valuable opportunity to address important scientific questions related to visual
learning and brain plasticity. With support from NIH and philanthropic foundations, Project Prakash is operationalized as
a three-part effort, comprising rural outreach, medical treatment and scientific research. The highly regarded Dr. Shroff's
Charity Eye Hospital in Delhi serves as our medical partner. Pursuing its dual mission of service and science, the initiative
has provided ophthalmic screening to over 62,000 children, sight restoring surgeries to over 520 blind children, and non-
surgical care to over 2000 others.
Several of the children treated for long-standing congenital blindness have gone on to participate in scientific studies
designed to probe the development of visual proficiencies and cortical changes after sight onset. Following their visual
progress has demonstrated both the possibility of, as well as constraints on, functional gains after several years of severely
compromised pattern vision. Even as Prakash children are found to exhibit persistent impairments in basic aspects of
visual function, such as acuity and contrast sensitivity, they are able to acquire complex object perception skills in the
months following surgery. Building on these results, our goal now is to elucidate the mechanisms that underlie the
observed limitations and proficiencies in post-surgical development. Using psychophysical, electrophysiological, and
neuroimaging techniques, we will attempt to determine, on the one hand, the neural bottlenecks that limit recovery and, on
the other, the mechanisms, both neural and functional, that act as enablers of functional gains in object perception.

Public health relevance
Project Narrative The goal of Project Prakash is to merge basic scientific research with societal service. The project identifies congenitally, but curably, blind children in India who have so far remained untreated due to poor medical access. By providing them corrective surgery, and following their subsequent progress, we gain a powerful vantage point to study the development of vision. The current project aims to query the neural and functional mechanisms associated with some of the key limitations and proficiencies that have emerged from our and our colleagues' research with late-sighted children.